Career Enhancement Program (CEP)

Project Summary/Abstract
The Career Enhancement Program (CEP) exists to identify, support, and mentor candidates with promising
independent careers in translational research. The CEP also represents an opportunity to encourage new and
established non-translational investigators, including women and minorities, to consider careers in translational
research. In this manner the program ultimately serves as a means to expand translational research, as well as
a source of translational projects and investigators for the SPORE Program itself. The Specific Aims of the
UCSF Brain Tumor SPORE CEP are: 1. To identify, support, and mentor individuals with promising careers in
translational brain tumor research 2. To encourage new and established investigators to develop careers in
translational brain tumor research. 3. To encourage women and minorities to pursue careers in translational
brain tumor research.

Public health relevance
Project Narrative The Career Enhancement Program is required component of all SPOREs and must be maintained for the entire funding period. Funds provided by the UCSF Brain Tumor SPORE, supplemented by funds provided by the UCSF Department of Neurological Surgery through the Helen Diller Family Comprehensive Cancer Center (HDFCCC), allow the SPORE to provide $50,000 direct costs for up to three CEP projects per year.